pA-regulator controlled, JMJD6 reprogrammed GPC3-CAR T cells for patients with hepatocellular carcinoma

CAR T cells mediate remarkable clinical responses in patients with hematologic malignancies but have shown
only modest benefit for patients with solid cancers. CAR T cell exhaustion is a critical barrier to therapeutic
efficacy in solid neoplasms and is marked by decreased proliferative capacity, cytokine production, and cytolytic
function driven by a fundamentally altered transcriptional and epigenetic landscape. Specific transcription and
epigenetic factors (TF/EFs) can modulate T cell exhaustion, but it is not known which TF/EF can prevent CAR T
cell exhaustion most effectively to safely maximize antitumor activity. We developed the CAR “Model to Optimize
Temporal ORFeome Responses” (MOTOR) platform consisting of a barcoded lentiviral library of all human TFs
and EFs that can be transduced into CAR T cells at 1 ORF / CAR T cell ratio and assessed in the pooled setting.
Our preliminary results demonstrate that specific ORF expressing CAR T cell populations enrich after repeated
tumor cell encounters and Jumonji Domain Containing 6 (JMJD6) is identified as top candidate. Precise, on-
demand control of TF/EF expression is necessary to maximize therapeutic efficacy and safety. Our recently
developed ‘pA-regulator’ platform controls gene expression on the RNA level, post-transcriptionally without using
foreign regulatory proteins. The system is based on a small ~400bp, non-protein coding sequence added 5’ of
the controlled transgene. It can provide a wide regulatable, dynamic range and exhibits an EC50 within FDA-
approved concentrations of tetracycline in humans helping implementation in patients. Thus, we hypothesize
that pA-regulator controlled overexpression of JMJD6 will safely prevent exhaustion and improve GPC3-CAR T
antitumor activity. In aim 1, we will examine all human TF/EFs (including JMJD6) to prevent exhaustion and
promote antitumor activity of GPC3-CAR T cells using repeat tumor challenge assessments in vitro in unbiased
forward genomics assessments followed by parallel evaluation of the top 5 candidates in additional functional
tests ex vivo and in tumor bearing mice. In aim 2, we will determine the tetracycline concentration for pA-
regulator controlled TF/EF expression to prevent T cell exhaustion leading durable antitumor responses of
GPC3-CAR T cells in vivo. We will examine the effect of turning “on” and “off” the pA-regulator and whether the
corresponding induction of JMJD6 or other top TF/EFs can reinvigorate GPC3-CAR T cells. To understand the
specific induced programs of exhaustion resistant CAR T cells, gene expression profiles, epigenetic alterations
and T cell subset composition changes will be evaluated in CAR T cells from peripheral blood and tumors.
Summary: The proposed research will provide an unbiased evaluation of all human TF/EFs and their role in
preventing exhaustion and promoting the antitumor properties of CAR T cells. The findings will provide in-depth
insight into regulation of exhaustion and a foundation for further clinical testing of pA-regulator controlled CAR T
cells in patients with cancer.

Public health relevance
The proposed research will study all human transcription factors and epigenetic modulators in T cells expressing a clinically validated Glypican-3-specific chimeric antigen receptor to overcome T cells exhaustion, an established barrier of antitumor function. The top candidates will be expressed under the control of our pA-regulator system to maximize safety and efficacy. The in-depth assessment of the epigenome, transcriptome and T cell phenotype will provide substantial mechanistic insight into the modulation and prevention of CAR T cell exhaustion.